Exploring Emotional Availability During Parent-Child Interaction in Children with Developmental Delays

Emotional Availability (EA), the synchrony between parents and children's affective and behavioral states, is
grounded in children's developmental abilities. Young children use motor behaviors to communicate their
wants and needs and parents use these observable motor behaviors to guide their interaction behaviors. As
development becomes more advanced, children and parents are able to interact with one another in new and
more complex ways, thus fostering global development. The proposed study builds on EA research in children
with typical development which highlights that children's linear change in EA over young childhood is mediated
by developmental abilities and that social adversities present challenges to adult and child EA. EA predicts
adaptive development, moderates adverse developmental outcomes in the presence of early adverse life
experiences, and guides intervention aimed at optimizing parents and children's health and well-being.
Evidence of EA in clinical populations is very scarce, with available studies having limitations in methodology
and findings are not yet replicated. Early intervention rehabilitation professionals working with children with
developmental delays often lack the training, resources, and support to assess and target EA as part of their
standard of care. The objective of this study is to advance the body of knowledge on the impact of motor skills
on the development of EA in young children with diverse motor abilities. Identifying delayed motor skills as a
risk factor for EA will highlight the need to assess and target EA as part of early intervention. Results from this
study will support the applicants long term career goals of creating research which optimizes children's
development, familial well-being and early intervention efficacy. The proposed study is a secondary analysis
and enhancement of prior collected data and includes 134 children with motor delays (7-16 months at
baseline) and 37 children with typical motor development (5-7 months at baseline) enrolled at the emergence
of sitting. Aim 1 will quantify the impact of motor skills on adult and child EA interaction behaviors. Aim 2 will
compare the impact of age vs. motor skills on EA in skill matched participants. Aim 3 will identify the predictive
relationship between baseline EA and the trajectory of children's motor development over 12 months. Post-hoc
analyses of each aim will describe the findings within the context of children's gender, socio-economic status
and race. Findings will provide foundational knowledge on constructs and behaviors which foster or impede
development of EA. This knowledge will be immediately informative in guiding therapists' decision-making in
practice and will inform future studies on developing clinically applicable assessment tools and designing
clinical trials that target EA as a pathway to enhance program efficacy. The fellowship proposal offers the
applicant training opportunities to execute a research study as principal investigator, expand current
knowledge base on parenting and complex statistical modeling, and increase scholarship by publishing in
competitive interdisciplinary peer-reviewed journals.

Public health relevance
PROJECT NARRATIVE Developmental delay, such as limited socialization, communication or motor activity, presents biological and social risks to both children and parents, which may complicate dyadic emotional availability during parent- child interaction and compound global delays. Given the predictive and moderating role of emotional availability on parents' and children's health and well-being, more research is needed to understand the impact of developmental delay on the development of dyadic emotional availability. Findings will support professionals working with children with developmental delays and their families in regard to allocating services to dyads most at risk; identifying adult and child behavioral characteristics which foster or impede emotional availability; and inform future clinical trials aimed at targeting emotional availability as a pathway to enhance efficacy of intervention.